Lysosomal ionic dysregulation in heart disease

PROJECT SUMMARY
The lysosome is emerging as a key regulatory hub within the cell, crucial for maintaining
homeostasis and viability under stress. This acidic, degradative organelle not only supports
metabolic adaptation through mitophagy and autophagic clearance but also plays a crucial role in
fine-tuning local signaling events via controlled ion release. While thus far lysosomal ionic
regulation has proven to be vital for cardiac homeostasis, its alteration in disease states remains
largely unexplored. Our recent findings reveal that the calcium/proton-permeable two-pore
channel (TPC2) is one of the most significantly altered lysosomal ion channels in cardiac disease,
with marked upregulation following acute injury that persists throughout heart failure progression.
Replication of this upregulation in vitro and in vivo demonstrates its pathogenic role, with elevated
TPC2 activity linked to increased cardiomyocyte death, exacerbated ischemia/reperfusion injury,
and progressive cardiac dysfunction. Mechanistic studies suggest that TPC2-mediated cell death
is likely driven by lysosomal calcium-induced mitochondrial calcium overload and subsequent
permeability transition pore (mPTP) opening. Additionally, proton efflux from hyperactive TPC2
appears to impair lysosomal acidification and autophagic clearance, further diminishing ischemic
stress adaptation. Accordingly, the proposed research will test the hypothesis that excessive
lysosomal TPC2 ion release significantly contributes to MI pathogenesis by promoting
cardiomyocyte death and weakened cellular resilience. We will address this hypothesis in two
specific aims:
In Aim 1 we will employ in vitro and in vivo genetic manipulations to determine whether sustained
increases in TPC2 activity drive ischemic pathological cardiac remodeling and decompensation,
and therapeutically test if TPC2-selective inhibition can prevent HF development
In Aim 2 we will leverage our range of lysosomal-targeted biosensors, molecular tools, and TPC2
gain- and loss-of-function models to explore how lysosomal calcium and proton efflux
independently influence cardiomyocyte resilience and survival, and additionally test whether
TPC2-dependent changes in post-MI remodeling preferentially favor one ionic pathway over the
other. The outcomes of this research will provide transformative insights into lysosomal ion
regulation, stress adaptation, and cell survival, paving the way for novel strategies to combat
ischemic heart disease.

Public health relevance
PROJECT NARRATIVE Ischemic heart disease (IHD) is a major global health challenge, leading to millions of deaths each year and enormous healthcare costs. The loss of cardiomyocytes and the reduced resilience of those that survive are critical factors contributing to IHD development. The goal of this project is to define how lysosomal two-pore channel (TPC2) upregulation contributes to weakened cardiomyocyte resilience and survival after a heart attack, and therapeutically test if TPC2-selective inhibition can curb IHD progression.